TOLERANCE IN CHRONIC EAE USING GENE THERAPY

DESCRIPTION (Adapted from the Applicant's abstract): The revised application now has five major aims: to generate syngeneic fibroblasts that contain a retroviral construct that encodes a PLP-miniprotein; to determine the potential amelioration of clinical signs and histologically-measured CNS inflammation provided by these fibroblasts; to determine the immune status of the treated animals versus controls to determine if there is evidence for intramolecular and intermolecular determinant spreading; to determine a direct correlation with the therapeutic effects of the fibroblasts and their ability to down-regulate IL-2 (and other cytokine) synthesis in the brains of treated and control mice with EAE; and finally to construct a hybrid vector containing epitopes from both PLP and MBP.